A first-in-class product for the clearance of high-risk human papillomaviruses

SUMMARY
Daré Bioscience is developing DARE-HPV, an innovative anti-viral vaginal insert to address the health threat
posed by persistent high-risk human papillomaviruses (HR-HPV) infections, which are associated with cervical
cancers. With a lack of FDA-approved treatments for persistent HR-HPV infections, this novel therapy combines
two antiretroviral drugs, lopinavir and ritonavir, targeting the viral lifecycle and restoring normal cellular growth.
A clinical proof-of-concept study showed promising results, with a significant proportion of women experiencing
HR-HPV viral clearance 12 weeks after a 14-day treatment. The proposed SBIR Phase II studies are focused
on achieving three main objectives to ensure DARE-HPV’s safety before submitting an IND application. First,
they aim to optimize and validate analytical assays for measuring the active pharmaceutical ingredients presence
in both blood and cervical samples. Second, they will conduct comprehensive intravaginal safety and toxicity
studies in a relevant biological model, female sheep. These studies are designed to confirm the absence of
clinical pathology and define the pharmacokinetic parameters in the blood and cervical tissue after
administration. Third, they will evaluate the potential for DARE-HPV dermal hypersensitivity and evaluate the
impact of DARE-HPV on condom integrity. Upon successful completion of these studies, Daré Bioscience
intends to file for IND status using the 505(b)(2) pathway, with Kaletra® as the reference drug.

Public health relevance
PROJECT NARRATIVE The introduction of DARE-HPV into the commercial market has potential to be the sole medical treatment for persistent HR-HPV infections, offering a vital option beyond the ambiguous choice of “watchful waiting”. DARE- HPV has high potential to reduce healthcare expenses, ease patient anxiety, improve quality of life, narrow cervical cancer health disparities, and cut HR-HPV spread, thereby contributing to overall improved public health.